Emerging Trends in Antibiotic Use and Their Impact on Primary Care for Children

DESCRIPTION (provided by applicant): Jonathan Finkelstein is an established pediatric patient-oriented researcher, with extraordinary opportunities to mentor junior scientists in studies of critical issues in child health and health care. A Mid-career Investigator Award in Patient-oriented Research (K24) will allow dedicated time for Dr. Finkelstein to improve his mentoring capacities, and to provide additional opportunities for mentees related to care for common infections and antibiotic use in childhood. Dr. Finkelstein will leverage his current NIH-funded studies, access to extensive automated data through the HMO Research Network (HMORN), and resources of Harvard's CTSC program to understand the significant changes in treatment of infections in primary care practice, including patterns of antibiotic use, in an era when resistance has become commonplace, new vaccines may dramatically affect childhood illness, and parent and physician attitudes are in flux. This revised application proposes a more integrated and comprehensive approach to studying recent trends in care-seeking and treatment of common infections. It uses analysis of population-level data, as well as focus group and survey methods to understand underlying changes in parent knowledge, attitudes, and care-seeking. It also proposes a new focus on health care disparities in treatment of common infections aligning it with one of the primary goals of the T32-funded fellowship program in pediatric research which Dr. Finkelstein leads. The proposed mentoring plan includes 1) increased focus on mentoring research fellows in the Harvard-wide Pediatric Health Services Research Fellowship Program; 2) development of new opportunities for mentorship within Harvard's recently funded NIH Clinical and Translational Science Center; and, 3) ongoing engagement in the HMORN to develop innovative programs for cross-site mentorship of child health researchers. The past decade has witnessed a dramatic monotonic decrease in the use of antibiotics in pediatric practice driven by concerns about resistance by parents and clinicians. This has been associated with changes in diagnosis of otitis media, and other changes in health care utilization. Prior work has suggested differences, by social and demographic factors, in antibiotic use rates, as well as parental knowledge and attitudes regarding treatment. Since these studies, however, both the epidemiology and social context of childhood infections has changed dramatically. Infections with resistant non-vaccine serotypes of S. pneumoniae and methicillin resistant staph aureus have become increasingly common; new universal immunization for seasonal influenza is being implemented; and, the current H1N1 influenza pandemic is likely to impact parental views of, and care seeking for, respiratory tract illness. This research will address critical remaining questions including: how much longer the rate of antibiotic use continues to decrease; what its nadir will be among children in the US; whether previously observed differences, by socioeconomic and demographic factors, in knowledge, attitudes, and prescribing rates narrow or increase; and, whether patterns of care seeking and treatment for respiratory tract infections will change in the context of pandemic influenza. Finally, this work will address the effectiveness of public health messages in diverse populations regarding both common infections and pandemic influenza. These aims will be met using mixed methods that include analysis of claims data for the diverse populations of 4 participating health plans (including the addition of a plan predominantly serving Medicaid members), focus groups of parents to assess changing parental attitudes, and a quantitative survey to assess changes in knowledge related to infections and antibiotic (and antiviral) prescribing. In addition to supporting his own work, the data streams and analytic methods developed here will allow Dr. Finkelstein's trainees to conduct high quality patient oriented research on conditions affecting both the future of pediatric primary care practice and child health in the US.

Public health relevance
Public Health Relevance: This work fills a critical public health need to understand trends in treatment of common infections, and antibiotic and antiviral use, in an era when resistance is a continuing concern. It will elucidate changes in parents' attitudes about treatment, as well as public health messages regarding pandemic flu and other infections. Methods developed here will be useful in studying many conditions affecting pediatric practice and child health. Public Health Relevance This work fills a critical public health need to understand trends in treatment of common infections, and antibiotic and antiviral use, in an era when resistance is a continuing concern. It will elucidate changes in parents' attitudes about treatment, as well as public health messages regarding pandemic flu and other infections. Methods developed here will be useful in studying many conditions affecting pediatric practice and child health. __SpecificAimsTextDelimiter__ 10. Specific aims Common infections in childhood highlight the nexus of medical care for individuals and the overall health of populations. Not only are the pathogens communicable, but the treatments themselves have consequences for the entire community, such as development of resistant pathogens. Over many decades, physicians largely ignored the population-level consequences and focused only on the patient in front of them-- their illness as well as their perceived or explicit desires. Now, there is certainly appreciation of the public health consequences of antibiotic use, and the recent H1N1 influenza pandemic has brought renewed attention to issues of population health more generally. Any clinician knows, and previous research has shown, that treatment of pediatric infections in primary care is not the result of a single, evidence-based decision in an examination room. Who gets a prescription for an antibiotic (and increasingly for an antiviral agent) depends on patterns of care seeking by parents, which is in turn driven by knowledge and attitudes about infectious illness. Parents bring to the encounter immediate concerns about their child's health, and a set of expectations and desires with regard to treatment.10 These may vary by parents' educational level, cultural factors, and prior (and ubiquitous) experience with common infections themselves. Physicians also enter an episode of care with their own knowledge, judgments, and biases.11 Trends in antibiotic prescribing measured as population-based antibiotic use rates, for example, are the end result of this complex cascade. We know a great deal about trends toward lower rates of antibiotic use in the late 1990's and early 2000's, However, critical questions remain that will be addressed by this research. They include: for how much longer will rates of antibiotic use continue to decrease, and what will be the nadir of the rate of use among children in the US; how will patterns of care seeking for common infections (e.g. respiratory tract infections) change and how will these vary by socioeconomic and demographic characteristics; and, how will the emergence of H1N1 influenza in 2009 (and new immunization practices) change attitudes and care-seeking for respiratory tract illness. In this revision, the elements designed to investigate secular trends in antibiotic use using health plan data have been retained, although consolidated into a single aim (aim 1). The addition of a predominantly Medicaid health plan will add substantial demographic diversity to the geographic diversity that existed in the original proposal that included data from Massachusetts, Minnesota, and Colorado, and will allow us to focus specifically on differences by socioeconomic and demographic attributes of parents. The two remaining aims have been changed considerably, in response to the strong suggestion by the reviewers that the work include direct contact with patients to investigate underlying changes in beliefs, attitudes and behaviors that account for observed epidemiological data. The second aim uses mixed methods to study the reasons for differences (and perhaps disparities) in prescribing among patients with varying socioeconomic and demographic characteristics. Finally, a third aim has been added in response to the new H1N1 influenza pandemic, which is likely to have important ramifications on care-seeking and treatment for respiratory tract illness in children. The revised specific aims of this revised proposal are, therefore: 1. To determine trends in rates of care-seeking and prescribing for common infections in young children from 2000 to 2014, including specific focus on: a. Antibiotic use for respiratory tract illness since the introduction of changes in immunization recommendations and new guidelines for treatment of acute otitis media. b. Care for skin and soft tissue infections as the prevalence of community-acquired MRSA becomes an increasing concern to parents and clinicians. c. Care-seeking and anti-viral use for influenza-like illness in the context of the H1N1 pandemic beginning in 2009. 2. To investigate differences in parental attitudes, care seeking, and prescribing according to socioeconomic and demographic characteristics including: a. Differences in population level trends by health insurer (Medicaid vs. private) and other attributes using geocoding of health plan enrollees and census-based information. b. Differences in parental knowledge, attitudes, and behaviors regarding respiratory tract infections, and antibiotic and antiviral use, through focus groups and parent surveys. 3. To investigate differences, by socioeconomic and demographic characteristics, in parental knowledge and attitudes toward public health messages and measures for influenza control and prevention in the wake of a novel H1N1 influenza pandemic.